Per- and Polyfluoroalkyl Substances (PFAS) Exposures and COVID-19 Vaccine Effectiveness

PROJECT SUMMARY/ABSTRACT
Infection with SARS-CoV-2 and its associated disease state, COVID-19, has resulted in over 374,000 deaths in
the United States to date. Vaccines protecting against COVID-19 have recently received FDA emergency use
authorization and are being administered to high-risk individuals with wider dissemination to follow. Exposure to
per- or polyfluoroalkyl substances (PFAS) is associated with reduced immune response following vaccination
against other infections, but its effect on COVID-19 vaccine effectiveness is not known. We have a time-sensitive
opportunity to determine the effect of serum PFAS on response to COVID-19 vaccination, building on a unique
study in ~2,000 healthcare workers, first responders and other essential workers in Arizona without prior COVID-
19 infection, many of whom have either recently been vaccinated or will be vaccinated in the coming months,
supplemented by ~700 additional participants from a similar study in both Arizona and Florida. Our objective in
this application is to determine the effects of PFAS exposure levels on COVID-19 vaccine effectiveness. Our
central hypotheses are that increased PFAS serum concentrations will: 1) reduce initial SARS-CoV-2 antibody
titers following COVID-19 vaccination; 2) increase the rate of longitudinal decline in antibody titers; and 3)
increase the frequency of COVID-19 during a nine-month period following vaccination. The rationale for this
research is that successful completion can be expected to provide new data about the immune effects of PFAS
exposure. We will test these hypotheses through two regular and one exploratory specific aims: 1) Evaluate the
association of serum PFAS with initial SARS-CoV-2 antibody titers following COVID-19 vaccination; 2) Evaluate
the association of serum PFAS with longitudinal decline in SARS-CoV-2 antibody titers following COVID-19
vaccination; and 3) Evaluate the association of serum PFAS concentrations with frequency of COVID-19
following vaccination. For aims 1 and 2, we will select 600 of our Arizona study participants for measurement of
serum PFAS following COVID-19 vaccination. As part of the study, these participants will also provide serum for
measurement of SARS-CoV-2 antibodies every three months for at least nine months, and provide respiratory
samples weekly for PCR testing to identify SARS-CoV-2 infection. For the exploratory aim, we will identify all
COVID-19 cases following vaccination in both the Arizona and Florida study populations, and for each case
select five matched controls who received COVID-19 vaccination but were not infected with SARS-CoV-2. Serum
PFAS levels will be compared across the cases and controls. At study completion, we will have documented the
effects of PFAS exposure on SARS-CoV-2 antibodies following COVID-19 vaccination and the frequency of
COVID-19 cases following vaccination. The proposed research is significant given the potential for PFAS
exposure to reduce the effectiveness of COVID-19 vaccines. The proposed research is innovative as it is the
first to our knowledge to determine the association between serum PFAS levels and measures of COVID-19
vaccine effectiveness.

Public health relevance
PROJECT NARRATIVE Exposure to per- and polyfluoroalkyl substances PFAS has the potential to reduce the effectiveness of vaccination against SARS-CoV-2 (COVID-19) infection. This proposed research will document the effects of PFAS exposure on SARS-CoV-2 antibodies following COVID-19 vaccination.